Genetic Regulation of Cochlear Development

PROJECT SUMMARY
The mammalian inner ear contains six sensory organs specialized for hearing and balance. They derive from
prosensory patches that arise at unique locations in the developing inner ear and then receive patterning
signals that cause them to develop into vestibular organs (cristae and maculae) or the auditory organ of Corti.
Our lab and others have identified some of the signals that drive these inductive and patterning events, such
as the Notch, BMP, Fgf, and Shh pathways. It is increasingly clear that dysfunction of these pathways can also
lead to developmental ear defects and hearing disorders in humans. However, despite the progress that has
been made in understanding these signals in the ear, fundamental questions remain about how they regulate
sensory organ induction and patterning. Moreover, it is likely that many other genes and pathways that
regulate ear development have still to be identified. The goals of this proposal are to use new genetic tools and
advances in single cell transcriptome analysis to understand the mechanism by which Notch and BMP
signaling generate and pattern inner ear sensory organs (Aims 1 and 2), and to leverage existing resources at
Baylor College of Medicine to search for new genes that regulate ear development and function (Aim 3).

Public health relevance
PROJECT NARRATIVE The goal of this proposal is to seeks to understand how two sets of signals, the Notch and BMP signaling pathways, play important roles in forming the hearing and balance organs of the inner ear. In addition, we will perform a screen of about a thousand new mice from the NIH-funded KOMP3 project, to identify new genes and signals that affect the development and function of the inner ear.